Secretion of mitochondria as a cellular quality control mechanism

Project summary
In the heart, the primary function of mitochondria is to meet the high energy demand of the beating
myocytes by providing ATP through oxidative phosphorylation. However, mitochondria can quickly change into
death-promoting organelles. Not surprisingly, cells have developed multiple defense mechanisms against
aberrant mitochondria that can cause harm to the cell. The ability to eliminate dysfunctional mitochondria and
prevent unnecessary death is particularly important in post-mitotic myocytes that cannot be easily replaced. It is
well established that dysfunctional mitochondria are rapidly sequestered by autophagosomes and subsequently
delivered to lysosomes for degradation. Recent studies have identified cells that can also eliminate mitochondria
via a Rab9-dependent alternative autophagy pathway or via a Rab5-dependent-early endosomal pathway.
Mitochondria can also be directly taken up by lysosomes. Clearly, multiple pathways of mitochondrial elimination
exist in cells to prevent their accumulation and ensure survival. However, these degradation pathways all
converge at the level of the lysosomes and it is not clear whether alternative mitochondrial quality control
pathways exists when lysosomal function is compromised. We have discovered that dysfunctional mitochondria
can also be secreted from cells when internal degradation pathways are overwhelmed or impaired. Our
preliminary data demonstrate that Rab7-/- and LAMP2-/- cells that have impaired lysosomal degradation are still
able to efficiently eliminate depolarized mitochondria. We also found increased levels of circulating extracellular
vesicles (EVs) containing mitochondria in plasma after a myocardial infarction, as well as in cardiac specific
Rab7- and LAMP2-deficient mice at baseline. Proteomics analysis of EVs combined with Western blot analysis
suggest that the mitochondria are in vesicles that originate from the endosomal pathway. In this proposal, we
will investigate the hypothesis that dysfunctional mitochondria are secreted from cells in EVs and that this
represent an important quality control pathway in the heart that can compensate when lysosomes are
overwhelmed or compromised. This hypothesis will be tested with two specific aims. Specific aim 1 will identify
the origin and fate of the extracellular vesicles containing mitochondria and determine the pathophysiological
conditions that induce their release from myocytes. Specific aim 2 will dissect the molecular mechanisms
regulating secretion of mitochondria in EVs. Overall, these studies will provide important new insights into a
novel alternative mechanism of mitochondrial elimination in the myocardium. The studies will also provide
insights into whether these EVs can potentially function as early diagnostic biomarkers of cardiac stress prior to
development of disease.

Public health relevance
Project Narrative Mitochondria are important in providing energy for the contracting myocyte, but dysfunctional mitochondria can be harmful to the cell. This project will provide important new insights into the mechanisms of mitochondrial clearance in the myocardium and how defects in this process contribute to cardiovascular disease.